The Role of GABA Co-release from Dopamine Neurons in Ethanol Consumption

Project Summary This supplement will greatly help the burden caused by childcare costs in Palo Alto, CA. These costs amount to more than $16,212/year. My daughter has been enrolled in the Stanford childcare since March 2021, before the beginning date of this grant. She will continue to be enrolled for the forseable future. Thank you for considering!

Public health relevance
PROJECT NARRATIVE About 70 million American have struggled with alcohol use disorder (AUD) at some point in their lives. However, there are only 3 FDA approved treatments, one of which was developed almost 100 years ago. Using state of the art techniques in neuroscience, this research will explore how a gene linked to AUD leads to enhanced ethanol consumption and will provide strategies to reverse the propensity for excessive drinking.